Disease pathophysiology in a murine model of TTP

DESCRIPTION (provided by applicant): This proposal describes a five year research program investigating pathophysiology of the human thrombotic disease thrombotic thrombocytopenic purpura (TTP). The PI and co-PI are both relatively new Assistant Professors in Hematology/Oncology at the University of Iowa. Other personnel will include research assistants, post-doctoral associates, and graduate students. The experiments proposed focus on understanding the pathophysiology of TTP, an uncommon but serious human thrombotic disease that still carries and ~20% mortality rate. The PI has already developed an animal model of TTP, which will be used to examine in detail, the role of the blood clotting protein, von Willebrand Factor, in this disease. These studies have the potential to further our understanding of TTP, a complex and important disease in humans. This research will build upon the applicant's prior research experience in this field, and it is anticipated that it will contribute greatly to his beginning career as an independent investigator. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page PUBLIC HEALTH RELEVANCE: We are investigating the human blood clotting disease TTP. This is a rare, but serious disease (1 case per 250,000 people per year). Unfortunately TTP strikes usually without preceding symptoms, usually in people less than 50 years of age. Mortality for this disease is still ~ 20% and treatment also carries significant risks.

Public health relevance
We are investigating the human blood clotting disease TTP. This is a rare, but serious disease (1 case per 250,000 people per year). Unfortunately TTP strikes usually without preceding symptoms, usually in people less than 50 years of age. Mortality for this disease is still ~ 20% and treatment also carries significant risks.